Engagement and Communication Between Proteasomal Subcomplexes

Project Summary Abstract
The 26S proteasome conducts most regulated protein degradation and eliminates toxic proteins from cells. The
proteasome is a validated anti-cancer target, and holds substantial promise as a target for treatment of
neurodegenerative disorders and some infectious diseases. Our long-term goal is to understand how the three
major complexes of the proteasome—the lid, base, and core particle—engage and communicate within and
between one another. We have thus far made significant progress toward this goal and have developed a number
of novel tools and reagents that have furthered our understanding of intra- and inter-complex communication.
Conceptual advances have included: i) discovery of additional conformational states of the yeast proteasome
relevant to substrate catalysis; ii) demonstration that six highly similar ATP-hydrolyzing subunits differentially
influence the activation state of the proteasome; iii) discovery of a link between the conformational state of the
proteasome and release of a dedicated proteasome assembly chaperone; and iv) and the finding that
proteasomal subcomplexes disengage one another prior to their destruction by autophagy.
A paradigm emerging from this initial budget period is that rather small binding events or molecular movements
are transmitted, often over long distances, to enact largescale conformational changes. Understanding how such
local events are amplified and transmitted to distant areas of the proteasome to coordinate assembly and
catalysis is thus a critical knowledge gap. In this first renewal, we propose three Aims that explore examples of
this paradigm newly discovered by us during the initial budget period. Together, they will push our knowledge of
proteasome dynamics and inter-complex communication into new arenas. In the first, we will use newly
developed FRET-based kinetic assays to decipher how local changes to the lid-base interface regulate the timely
binding and release of dedicated assembly chaperones from nascent proteasomes. In the second, we will
explore a surprising allosteric conduit originating from the substrate unfolding center of the proteasome that
regulates the stability between two key subcomplexes. In the third Aim, we will investigate an unusual eukaryotic
proteasome from a poorly studied human parasite from the phylum of Microsporidia. Microsporidia lack several
proteasome subunits that normally span a key inter-complex interface. The missing subunits contain several
small sequence elements with essential roles in assembly and catalysis in other eukaryotes, so exploring these
unusual proteasomes will thus reveal both conserved and unique elements of inter-complex communication.
These studies are anticipated to produce important insights into the engagement and communication between
the proteasomal subcomplexes, significantly advancing several aspects of proteasome biology and drug
discovery. Further, microsporidia are NIH priority pathogens of interest for which no broadly effective treatments
exist. Insights into microsporidial proteasomes thus may reveal new targets to combat certain parasitic infections.

Public health relevance
Project Narrative The goal of this project is to understand the communication and coordination of the moving parts within a molecular “recycling center” called the proteasome. The proteasome is an emerging drug target for numerous human diseases, including some cancers, several neurodegenerative disorders, and a number of infectious diseases. Understanding this communication will help us to design new treatments for these diseases that work by controlling protein recycling inside cells.